Machine learning approaches for improved accuracy and speed in sequence annotation: supplement for software enhancement

Summary The goal of this parent grant for this supplement request is to develop Machine Learning approaches to improve both accuracy and speed of highly-sensitive sequence database search and alignment. We have developed three software tools associated with this effort of correctly annotating genomes: (i) ULTRA, which labels repetitive sequence, (ii) PolyA which integrates such labels with other sequence annotations in a probabilistic framework, computing uncertainty and improving accuracy, and (iii) SODA, which aids in visualization of annotations and supporting evidence. Here, we describe a plan to refactor these software tools and their documentation to improve robustness and reliability, and to improve their availability through package management systems and incorporation into cloud-based analysis frameworks.

Public health relevance
Narrative This proposal describes a plan to improve the quality of existing software from the Wheeler lab that supports accurate annotation of biological sequences (ULTRA and PolyA), and visualization of such annotation (SODA). The emphasis of this effort is on software engineering, documentation, and package management, with a specific plan to prepare the tools for use in the cloud.